RESEARCH SUPPORT SERVICES FOR THE ADOLESCENT BRAIN COGNITIVE DEVELOPENT (ABCD) STUDY AND HEALTHY BRAIN & CHILD DEVELOPMENT (HBCD) STUDY

Adolescent Brain Cognitive Development (ABCD) Study
The Adolescent Brain Cognitive Development (ABCD) Study is the largest long-term study of brain development and child health in the United States. The National Institutes of Health (NIH) funded leading researchers in the fields of adolescent development and neuroscience to conduct this ambitious project. The ABCD Research Consortium consists of a Coordinating Center, a Data Analysis, Informatics & Resource Center, and 21 research sites across the country, which have invited 11,880 children ages 9-10 to join the study. Researchers will track their biological and behavioral development through adolescence into young adulthood.
Using cutting-edge technology, scientists will determine how childhood experiences (such as sports, videogames, social media, unhealthy sleep patterns, and smoking) interact with each other and with a child’s changing biology to affect brain development and social, behavioral, academic, health, and other outcomes.
The results of the ABCD Study will provide families; school superintendents, principals, and teachers; health professionals; and policymakers with practical information to promote the health, well-being, and success of children.
https://abcdstudy.org

HEALthy Brain and Child Development (HBCD) Study
NIH is supporting research to better understand brain development, beginning in the perinatal period, and extending through early childhood, including variability in development and how it contributes to cognitive, behavioral, social, and emotional function. Knowledge of a wide range of brain trajectories is critical to understanding how they may be affected by exposure to opioids and other substances (e.g., alcohol, tobacco, cannabis), stressors, trauma, and other significant environmental influences, including those that promote resilience.
The HEALthy Brain and Child Development (HBCD) Study will recruit a large cohort of pregnant individuals and follow them and their children through early childhood. The study will collect information beginning at birth and continuing through early childhood, including structural and functional brain imaging; anthropometrics; medical history; family history; biospecimens; and social, emotional, and cognitive development.
Knowledge gained from this research will be used to better understand prenatal and postnatal exposure to environmental conditions and help identify resilience factors that may mitigate adverse outcomes.
https://heal.nih.gov/research/infants-and-children/healthy-brain